Hippocampal and frontoparietal mechanisms for knowledge acquisition and inference

PROJECT SUMMARY/ABSTRACT
Hippocampus (HPC) structure and its connectivity with frontoparietal regions continue to develop through
adolescence, a developmental period associated with substantial gains in memory and reasoning. While such
structural changes are well documented, we know less about the functions that HPC and frontoparietal
development confer, fundamentally limiting our understanding of the mechanisms through which individuals
learn and reason about the world at different ages. From very early in life, children can learn simple
associations that they directly experience. However, with age, our memories become more complex, reflecting
not only directly observed information, but also knowledge derived across multiple episodes. Such derived
knowledge might represent commonalities among experiences while simultaneously exaggerating important
differences between them, thus forming hierarchical knowledge structures that can support inference decisions
about event relationships, while also preserving detailed memory for when and where those relationships vary
by context. The overarching goal of this proposal is to test the hypothesis that representational capacity within
HPC and frontoparietal cortex undergoes qualitative changes during adolescence. We will use a serial cohort
design to collect data from adolescents (13-18 years) at three timepoints, each 1.5 years apart, as well as data
from adults (19-25 years) at a single timepoint. This design will allow us to test longitudinal predictions about
how changes in neural representation within individual adolescents, over time, predict corresponding changes
in memory and inference behaviors, as well as cross-sectional predictions about how HPC and frontoparietal
cortex representation differs between adolescents and adults. We will use high-resolution functional magnetic
resonance imaging (fMRI), representational fMRI analyses, and computational modeling, to test three Aims.
Aim 1 will test the prediction that HPC and ventromedial prefrontal (vmPFC) representations will transition from
coding simple, individual associations to extracting hierarchical knowledge about the relationships among
experiences. Aim 2 will test the prediction that lateral parietal cortex (LPC)-mediated memory reactivation
during new learning and inference will have different consequences for HPC—vmPFC representation and
inference behavior at distinct points in adolescence. Aim 3 will test the prediction that emerging vmPFC control
will influence what memories are available in LPC during learning and inference, as well as directly mediate the
impact reactivated memories have on the trajectory of HPC representation during adolescence. The results
from this project will provide a key test of fundamental theories of cognitive development and substantially
advance our knowledge of the representational capacities of the HPC—frontoparietal memory system in
typically developing adolescents. In doing so, the findings may have important implications for our eventual
understanding of how the onset of mental health disorders (e.g., affective disorders and schizophrenia) during
adolescence impact neural representation as well as memory and reasoning ability.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed research investigates how hippocampal and frontoparietal function the human brain undergoes qualitative changes during adolescence, leading to improvements in memory and reasoning abilities during emerging adulthood. A growing body of empirical work has shown that difficulties with memory and reasoning in development are associated with poor academic outcomes, as well as with several mental health disorders with developmental onsets, including affective disorders and schizophrenia. Isolating the neural mechanisms that underlie changes in memory and reasoning ability during adolescence may thus help identify markers of atypical development and contribute to interventions that may improve both cognitive and academic outcomes.